Multidisciplinary training in basic and translational Alzheimer's disease research

PROJECT SUMMARY/ABSTRACT
This new application for an institutional T32 program is designed to provide advanced translational
research training on Alzheimer's disease and AD related dementias (ADRD). This proposal builds
on the outstanding research and training environment of UCSD and participating neighboring
institutions (The Salk Institute, Sanford-Burnham-Prebys Institute, and The Scripps Research
Institute) as well as leveraging the resources of the UCSD Alzheimer's Disease Research Center,
the AD Collaborative Study, and other affiliated programs. To take advantage of the unique
opportunities of our research community, we will offer focused but also multidisciplinary
approaches to training four pre- and four postdoctoral (MD, PhD, or MD/PhD) trainees to prepare
them to tackle the challenges of ADRD due to population aging. The program has three key
features: 1. Academic bridging - A principal focus will be to provide the predoctoral students
and postdoctoral fellows with concepts and research tools necessary to address issues at the
interfaces of basic, translational, and clinical questions in ADRD research. This bridging will be
reflected in the diverse interests and expertise of the participating faculty, the nature of the
projects proposed by the trainees, and the training plan itself which includes formal didactic
teaching and less formal seminars, journal clubs, interactive sessions with faculty, and scientific
retreat. 2. Multidisciplinary Approach - By its very nature, neurosciences is a multidisciplinary
field of investigation. The training faculty brings to this Program expertise, experience, and
technical knowledge in a variety of approaches and disciplines. Our goal is to train future
investigators who are to work and think effectively in several of these areas. This will be achieved
by choosing the best faculty, by bringing together trainees and mentors who are open to
interdisciplinary exchange of ideas and approaches, and providing them a forum for instruction,
discussions, and interactions. In addition, we hope to draw into the ADRD community faculty
members who have recently expanded their research efforts into ADRD or who have expertise in
related areas or in technologies that can expand the scope of ADRD research. 3. Mentorship –
An integral aspect proposed for this Training Program is the attention to mentorship. In addition
to the trainee's own research mentor/supervisor, each trainee will select a co-sponsor chosen to
provide more multidisciplinary input and oversight into his/her research. Junior faculty members
will also be assigned a mentor chosen from the Executive Committee of the Training Program to
provide advice and support in order to advance their academic trajectory and enhance the
success of their laboratory trainees.

Public health relevance
PROJECT NARRATIVE This new application for five years support is to provide advanced training to predoctoral and postdoctoral fellows in translational research in Alzheimer's disease and related dementias. The aging of the US population means a continued need for new investigators trained in the study of the age-associated brain diseases, especially dementia disorders, with a focus on the latest technologies and scientific approaches. This Training Program uses a multi-disciplinary approach through didactic instructions, courses, seminars, talks, and advisory groups to prepare the trainees for research careers in focused on Alzheimer's disease and related dementias.